Development of Passive and Sustainable Cometabolic Systems to Treat Complex Contaminant Mixtures by Encapsulating Microbial Cultures and Slow Release Substrates in Hydrogels

Introduction:
Request for Diversity Supplement to the R01 Research Project: Development of Passive and Sustainable
Cometabolic Systems to Treat Complex Contaminant Mixtures by Encapsulating Microbial Cultures and
SlowRelease Substrates in Hydrogels (R01 ES032707).

Public health relevance
The proposed supplement will support continued research relevant to public health, to develop a sustainable technology for the passive bioremediation of complex mixtures of groundwater contaminants, including chlorinated solvents and 1,4-dioxane via aerobic cometabolism. The co-encapsulation of pure cultures of bacteria along with slow release compounds in hydrogels beads has the potential to lower costs and achieve high treatment efficiencies. The beads can be used to treat a broad range of contaminants and in many different platforms, including permeable reactive barriers.